Facilitating Access to Information on Human Proteins and Their Phosphorylation

Protein phosphorylation is one of the most fundamental signaling processes in eukaryotic cells and in human disease. Since phosphorylation of any site on a given protein can change the function or localization of that protein, understanding the "state" of a cell requires knowing the phosphorylation state of its proteins. Identification of key phosphorylation sites and generation of phospho-specific antibodies have proved to be critical for basic research and for clinical diagnosis, especially relating to cancer biology. It is essential to have an expert-curated web-accessible unified source of information on such sites and phospho-specific antibodies, in order to facilitate use of such antibodies in basic and pre-clinical research. The MPR (Mammalian Phosphorylation Resource) is a unique resource for this information and for related information on phosphorylation biology.